Research Training in Natural Product Complementary and Integrative Health

Project Summary/Abstract
The University of Illinois Chicago (UIC) College of Pharmacy is the third oldest of the 100+
pharmacy colleges in the U.S., founded in 1859, and even older than the University of Illinois
itself. Our College consistently ranks in the top five nationally for NIH funding and overall research
expenditures (AACP statistics). Enrolling an average of 120 graduate students and 20
postdoctoral researchers at any one time, this renewal application seeks continued support for
our long-standing program for natural products research and graduate/postgraduate education.
This program has two major elements: the Pharmacognosy Institute (PHCI), a UofIL-accredited
research unit that evolved from Prof. Farnsworth's Program for Collaborative Research in the
Pharmaceutical Sciences (PCRPS) and the UIC Center for Botanical Dietary Supplements
Research; and the Department of Pharmaceutical Sciences (PSCI), the academic home
department of most of the mentors, graduate students and postdoctoral researchers in this
proposal. The natural product program at UIC enjoys a global reputation of excellence in graduate
and postgraduate training, with several hundreds of alumni worldwide. Its signature is the
emphasis on interdisciplinary and collaborative approaches to graduate and postgraduate
education in natural products of biomedical relevance. PSCI offers a graduate program in
pharmaceutical science with a pharmacognosy and three other tracks with strong natural product
components, as well as a postdoctoral and scholarly training and exchange program that includes
the UIC WHO Traditional Medicines Collaborating Center. Three additional research units, the
UICentre (drug discovery), the Center for Biomolecular Sciences, and the Institute for
Tuberculosis Research have expanded the educational opportunities for our trainees, especially
in the outgoing Year 6-10 cycle. Mentored by a large group of well-funded faculty with expertise
in biomedical natural products research, our graduates move on to leadership positions in
academia, industry, regulatory, and government, predominantly in the U.S. but also globally.
Training young scientists for careers in natural products research and health products is a core
mission of our College of Pharmacy, the PHCI and PSCI, and the focus of this training grant.

Public health relevance
Project Narrative Natural products are both an essential source of novel drugs and widely used by the U.S. public as dietary supplements in and for self-medication. This training program will continue to support the education of the next generation of scientists with the knowledge and skills to discover new therapeutic agents and be responsible for establishing the safety and efficacy of health products from natural sources.